Longevity Consortium

ABSTRACT: THE LONGEVITY CONSORTIUM (LC). Multiple studies of model organisms and humans have
suggested that genetic variants, proteins, metabolites, as well as other biomolecules and molecular-
physiologic processes, could play roles in mediating longevity, healthspan, and age-related disease in
humans. Unfortunately, the direct relevance of many of these factors to human longevity, healthspan and
age-related disease is uncertain, as is the amenability of these factors to pharmacological modulation.
Therefore, well-integrated and sophisticated research strategies are needed to determine the degree to which
various factors both influence human longevity and are amenable to pharmacological manipulation. The
Longevity Consortium (LC) has a history of precedent-setting studies seeking to identify factors that
influence human longevity and healthspan and has recently redefined its goals and research
strategies to achieve an appropriate level of integration and sophistication to elucidate additional
factors affecting longevity, as well as their interactions and translatability into targets for
pharmacotherapeutic manipulation. To enable appropriate integration in human longevity research, the LC
will exploit a multiple investigator structure with 5 interlinked research projects and 3 integrative cores. These
projects and cores will include: A cross-species project focusing on cellular and organismal phenotypes led by
Richard Miller (referred to as the Miller-Mice/Cell project hereafter); a metabolomics project led by Oliver
Fiehn (Fiehn-Metabolomics); a Centenarians project co-led by Thomas Perls and Paola Sebastiani (Perls-
Centenarian); a proteomics project led by Eric Orwoll (Orwoll-Proteomics) and a disease context project led
by Nicholas Schork (Schork-Disease Context). The cores include a Systems Biology core led by Nathan
Price (Price-Systems), a Chemoinformatics core led by Thomas Girke (Girke-Chemoinformatics), and an
administrative core with an overall administrative component led by Steve Cummings (Cummings-Admin)
and a scientific integration component led by Nicholas Schork. Drs. Cummings and Schork, as Multiple PIs,
will share responsibility for the overall leadership of the LC effort. The proposed LC will complement, and
partner with, an NIA-funded U24 project (U24AG051129) involving many LC investigators to construct a
website for data dissemination.
1

Public health relevance
The Longevity Consortium (LC) renewal proposal is rooted in the belief that integrated approaches to the discovery of factors affecting human longevity must be pursued. The proposed LC research will therefore include 5 research projects and 3 cores, all focusing on, and leveraging, very complementary high-throughput assays, large cohorts and novel analytic methods. An emphasis will be placed on systems biology and chemoinformatics analysis to help place the findings of each project into more coherent views of the molecular pathways and processes affecting longevity and their amenability to pharmacologic manipulation.